Legacy Project - Diversity Supplement

Project Summary: Legacy — what one leaves behind and how one hopes to be remembered after death— is an important part of the human experience. In the parent grant, our related preliminary work, we have encountered multiple anecdotal reports from people considering their legacy as they make cancer treatment choices, suggesting that legacy has a clear financial component and is relevant to understanding cancer-related financial hardship. However, very limited research exists about legacy planning as it relates to cancer care. Deeper understanding of the legacy construct and how it relates to cancer-related financial hardship and treatment choices could guide how to incorporate legacy considerations into financial navigation interventions like the one in the parent grant. This supplemental study will examine how people with cancer consider legacy, both in general and when making medical decisions, with focus on the financial aspects of legacy. Through a critical literature review and semi-structured interviews with cancer patients and their families, this study will build a conceptual model and preliminary data that will inform a future R01-level (or equivalent) research grant proposal led by Dr. Marlaine Figueroa Gray, junior faculty member, first generation college graduate, and member of an underrepresented minority group, at Kaiser Permanente Washington Health Research Institute.

Public health relevance
Narrative This supplemental study will investigate the conceptual foundations of legacy in health care, in the literature, and how legacy is conceptualized by people living with cancer and their caregivers. This study will examine the ways in which legacy considerations, especially financial legacy, influence the treatment decisions of people living with cancer.